Bispecific T cell engager targeting a highly specific tumor cell surface antigen

Abstract
We have identified a highly tumor specific cell surface antigen, ALPPL2 or ALPG, that is not expressed in any
normal tissue except for the placenta. ALPPL2 is expressed in a number of cancers including mesothelioma,
ovarian, lung, gastric, pancreatic, endometrioma, and testicular cancer. ALPPL2 is one of those rare cell
surface antigens that are genuinely tumor specific as opposed to tumor associated. The exquisite tissue
specificity makes ALPPL2 an attractive target for developing cancer therapies that require a high degree of
specificity. We propose to develop an ALPPL2-targeted bispecific T cell engager for treatment of ALPPL2
positive cancers. Target specificity is the hallmark of our new therapy development effort. In addition, we will
engineer the CD3 arm: (1) a low affinity CD3 arm has the potential of reducing target independent cytokine
release and thus gaining a wider therapeutic window; (2) tumor killing and cytokine release are mediated by
two thresholds that can be differentially impacted by CD3 arm engineering. A mild or minimal on-target
cytokine release is desired. Another important variable that affects developability and therapeutic window is the
molecular architecture on which the bispecific is constructed. In this proposal, we will address the three critical
issues, i.e., target specificity, CD3 arm optimization, and molecular architecture, and use a system engineering
approach to identify an optimized T cell engager with matching components and forms that impart it with an
excellent developability and a wide therapeutic window, enabling translation to clinical testing. In Aim 1, we will
generate ALPPL2 BiTEs with engineered CD3 arm variants in forms compatible with clinical translation. In Aim
2, we will study tumor-specific cytotoxicity and cytokine release of system-engineered BiTEs targeting the true
tumor specific antigen ALPPL2. In Aim 3, we will determine efficacy in vivo and identify a lead ALPPL2 BiTE
for clinical translation. Impact: Successful completion of the proposed study will lead directly to clinical
translation of a novel bispecific T cell engager with unprecedented tumor targeting specificity in multiple
incurable cancer types with dire clinical needs.

Public health relevance
Narrative We have identified a highly specific tumor cell surface antigen that is not expressed by any other normal tissue except for the placenta. We have also identified a human monoclonal antibody that binds to this tumor-specific antigen with high affinity and specificity. We propose to leverage this exquisite target specificity to develop a bispecific antibody with one arm targeting tumor and the other engaging the T cell with an optimized affinity to achieve highly potent and specific tumor cell killing without causing excessive cytokine release, and translate this novel immunotherapeutic to clinical trials in the near future.